IN VITRO FOLDING AND ASSEMBLY OF MHC MOLECULES

The aim of this project has been to develop in vitro systems for the study of the assembly and folding of the MHC class I molecules. Past studies have focused on coupled in vitro transcription/translation systems for examination of the assembly of the three chains of this macromolecule: the class I heavy chain, beta-2 microglobulin, and antigenic peptide. Recent results with in vitro mutants emphasize the value of such a system in evaluating parameters of assembly. Our current approach is to develop more biochemically defined methods, based on genetically engineered, bacterially produced single chain MHC class I proteins and synthetic antigenic peptides. We have demonstrated that biologically active, immunostimulatory MHC class I peptide complexes can be made by in vitro refolding of completely reduced and denatured molecules, suggesting that this is a feasible approach to produce large scale amounts of homogenous complexes for experimental use.